Understanding and Treating NAXD Deficiency Using Vitamin B3-Based Approaches

PROJECT SUMMARY
The past decade has seen significant interest in vitamin B3 therapies for age-associated conditions and
mitochondrial diseases, yet a systematic understanding of which disorders might benefit remains elusive. Here,
we present a focused investigation into NAXD deficiency, identified through genome-wide CRISPR screens as
a potential target for B3 therapy. Our research demonstrates that NAXD, a critical "proofreading enzyme" in the
NAD+ metabolism pathway, plays a pivotal role in preventing cellular dysfunction. Through the development of
a NAXD knockout mouse model, we aim to elucidate the organ-specific pathologies associated with NAXD
deficiency, including neuropathology, cardiac dysfunction, and skin lesions. Additionally, we seek to understand
the pathophysiology of NAXD disease, exploring both NADH depletion and the toxic effects of NADHX
accumulation on oxidoreductase function. Furthermore, we investigate the potential of environmental and dietary
interventions, including B3 megavitamin therapy and serine supplementation, in mitigating NAXD-associated
phenotypes. Our study not only offers insights into NAXD deficiency but also serves as a template for
systematically determining which diseases benefit from each vitamin.

Public health relevance
PROJECT NARRATIVE Our research focuses on understanding NAXD deficiency and its potential treatment through vitamin B3 therapy. Using a NAXD knockout mouse model, we aim to uncover the organ-specific pathologies and underlying mechanisms contributing to the disease, while also exploring the efficacy of dietary and environmental interventions. This study not only addresses the fundamental pathophysiology of NAXD deficiency but also informs the development of novel vitamin-based therapies.